Connectomic Deep Brain Stimulation for Obsessive Compulsive Disorder

Project summary
Treatment of severe obsessive-compulsive disorder (OCD) with deep brain stimulation (DBS) is
evolving to provide precision modulation of pathological brain circuits. One promising DBS target
for OCD is a large and complex white matter fiber bundle called the anterior limb of the internal
capsule (ALIC). A clear challenge to effective dissemination of this treatment is the lack of
specificity in targeting the necessary and sufficient ALIC pathways. To prepare DBS for broad
dissemination, we must build the knowledge and tools to enhance the precision with which
stimulation is applied to individual brains. The overarching hypothesis of the proposed research
is that DBS-mediated responses (clinical, behavioral, and electrocortical) reflect activation of
specific pathways traveling through the ALIC. In testing this hypothesis, our proposal will construct
an atlas of circuit- response maps, which can be used to guide clinical programming decisions
and enhance the precision of surgical targeting for ALIC DBS. Individuals receiving ALIC DBS to
treat OCD (n=20) will undergo 7T magnetic resonance imaging and electroencephalography, as
well as behavioral testing at multiple time points. Aim 1 will produce a connectome blueprint that
characterizes white matter pathways implicated in effective treatment of OCD. Aim 2 provides a
patient-level, electrophysiological read-out to indicate which pathways are stimulated at
tractography-defined locations in the ALIC. Aim 3 constructs a behavioral-connectome blueprint
by linking change in task performance to DBS at tractography-defined locations in the ALIC.
Combined, this research constructs a connectomic atlas for OCD using the association of white
matter structures, electrocortical response and behavioral outcomes to specify the ideal
anatomical target for DBS.

Public health relevance
Project Narrative Deep brain stimulation is an emerging treatment for individuals suffering from severe obsessive-compulsive disorder (OCD), which is a common and disabling neuropsychiatric condition. To prepare this treatment for broad dissemination, we must build the knowledge and tools to enhance the precision with which stimulation is applied to individual brains. This research constructs a connectomic atlas for deep brain stimulation in OCD using the association of brain pathways and optimal behavioral outcomes.